Transition from Acute to Chronic Pain in Total Knee Arthroplasty Patients: Identifying Resilience and Vulnerability Profiles

Per Dr. Laura Wander, this document is not required for the supplemental application for
UM1NS1112874.

Public health relevance
Per Dr. Laura Wander, this document is not required for the supplemental application for UM1NS1112874.